Toward Racial Equity and Justice in Human Papillomavirus (HPV) Vaccination: An Exploratory Study with Cape Verdean Parents

PROJECT SUMMARY
Human papillomavirus (HPV) is the most common sexually transmitted virus in the United States (U.S.). HPV infection is
linked to cancers of the cervix, vulva, vagina, penis, anus, and oropharynx, thus representing a significant public health
concern. The HPV vaccine is the most efficient and cost-effective mechanism for combating HPV infection and its cancer-
related consequences. Nonetheless, HPV vaccination rates for age-eligible adolescents remain suboptimal in the U.S.
Scientific evidence underscores the critical influence of sociocultural and contextual factors on parents’ acceptability and
uptake of the HPV vaccination. Sociocultural values, family expectations, health literacy, beliefs, attitudes, and knowledge
influence parents’ behaviors and decisions, healthcare-seeking and utilization, and health outcomes. Black women are
disproportionally affected by HPV-associated morbidity and mortality, with the second-highest cervical cancer incidence
rate, the second highest after non-Hispanic Whites and the highest cancer mortality rate. However, there is a lack of data
for African ethnic minority subgroups such as Cape Verdeans (CV) in the U.S, an ethnic minority group of mixed West
African and Portuguese roots. The U.S. is home to the largest CV population outside the country of Cape Verde, with an
estimated 265,000 CV immigrants and their descendants living in the U.S. CVs primarily reside (~90%) in Massachusetts
and Rhode Island. Understanding HPV and HPV vaccination knowledge, attitudes, and behaviors (KAB) of specific ethnic
minoritized and immigrant subgroups, such as CV, will make it possible to meet particular subgroup needs and improve
knowledge and practices, thereby improving health status and outcomes by decreasing cancer risk. Though recent research
has shown an increase in HPV uptake, but not necessarily HPV vaccine completion, among minority populations including
African Americans and Blacks, no data exist to show that this is the case for CV adolescents living in the U.S. Also, there
remains a paucity of data regarding HPV knowledge, attitudes, and behaviors of CV parents living in the U.S. Therefore,
the proposed study will focus on Cape Verdeans, a population group currently underrepresented in cancer health disparity
research, and seeks to: 1) explore the KAB regarding HPV and HPV vaccination (intention, hesitancy, barriers, initiation,
and completion) among CV mothers and fathers (Phase 1: Focus Groups); and 2) explore CV parents’ HPV KAB, health
communication, sociocultural factors, their intention to have their sons and daughters undergo HPV vaccination, HPV
vaccine hesitancy, barriers to HPV vaccination, and parent-reported receipt of HPV vaccine or refusal of the vaccine (Phase
2: Survey Administration). The proposed community-engaged research is innovative in that it will: 1) engage CVs, an
understudied ethnic minority and immigrant subpopulation currently underrepresented in HPV research, 2) include fathers
who are under-represented in HPV research, and 3) establish a partnership with Catholic and Protestant churches to further
assist with the important goal of addressing HPV vaccine myths and disseminating accurate HPV vaccine information to
CV communities. Moreover, it will provide a solid basis for the design of future linguistically and culturally tailored
education interventions to promote the HPV vaccine among CVs in the U.S. Moreover, this research will build further
research capacity to engage underserved, minority CV parents in future HPV and cancer prevention interventions.

Public health relevance
PROJECT NARRATIVE The proposed study seeks to assess Cape Verdean parents’ awareness, knowledge, attitudes, and behaviors related to the human papillomavirus (HPV), and acceptability and uptake HPV vaccination by their adolescents. This information is important to develop culturally sensitive HPV-related cancer education and prevention interventions that meet the specific needs of Cape Verdeans living in the United States.